CONTROLS OF APPETITE: INVESTIGATIONS USING ALLOXAN

Rats injected intraventricularly with alloxan appear to lack the glucoprivic control of feeding. Since such animals are not behaviorally or phsiologically impared, this deficit suggests that alloxan may be selectively toxic for brain cells which mediate some aspect of the glucoprivic control. Therefore, we propose to use intraventricular alloxan in combination with silver stain and other anatomical techniques to localize alloxan-damaged brain cells. Once identified, these cells will be subjected to further scrutiny to determine whether they are glucoreceptors or whether they are involved in some other aspects of glucoprivic feeding. We also propose to examine the meal patterns of intraventricular alloxan-treated rats under normal conditions and in response to homeostatic challenge to establish how normal feeding is altered by the loss of this one control. Recently, we have shown that subdiabetogenic hepatic portal alloxan injections abolish the satiety effect of exogenous pancreatic glucagon, without altering the satiety effect of cholecystokinin. We propose experiments to identify the mechanism and site of action of this alloxan effect and to determine how the loss of sensitivity to glucagon influences meal size and meal frequency. These studies may contribute to our understanding of brain and peripheral mechanisms which translate hunger and satiety signals into integrated behavioral responses.